Training Program in Hematology

The primary objective of the Training Program in Hematology, which will complete its 40th year of funding in
2024, is to train MD, MD/PhD, and PhD postdoctoral fellows interested in adult hematology for careers in
academic medicine and biomedical research. Johns Hopkins Hematology is among the largest free-standing
adult hematology programs in the nation. We request support for four postdoctoral trainees per year, which is
unchanged from the previous grant cycle. The Johns Hopkins Hematology Fellowship Program, which supports
three single-board hematology fellows per year, is the major substrate for this T32. This fellowship program is
one of a few programs in the United States that recruits for single-board hematology fellows, and provides
dedicated training in classical and malignant hematology without training in solid tumors. Thus, the purpose of
the training program is to prepare qualified individuals with an MD and/or PhD degree for a research career in
hematology. The training program consists of well-funded and highly experienced investigators, most of whom
are internationally recognized for their research on hematopoiesis and stem cell biology, anemias,
hemoglobinopathies, thrombotic microangiopathies, bone marrow failure states, bone marrow transplantation,
and myeloproliferative diseases. Training is enhanced by an outstanding research environment with state-of-
the-art research facilities and cores, exceptional faculty mentors, and an existing program project grant on bone
marrow transplantation. Despite a national trend away from single-board hematology fellowship programs, Johns
Hopkins continues to attract outstanding MD and MD/PhD candidates for single-board hematology training and
prepares them for careers in biomedical research1. There is also a strong pool of PhD postdoctoral fellows from
the labs of our basic science mentors who are well-integrated in the hematology multidisciplinary conferences
and even the clinical training program.
Specific aims of this training program are:
1) to provide research training opportunities in a variety of areas pertaining to hematology including
classical and malignant hematopoiesis, bone marrow failure disorders, bone marrow transplantation,
stem cell biology, immunology, genetics, thrombotic microangiopathies, hemoglobinopathies, and
myeloproliferative/myelodysplastic syndromes
2) to provide the opportunity for structured coursework and seminars pertaining to clinical, translational
and basic research pertaining to hematology, and to provide opportunities for instruction in grant
writing, manuscript writing, public speaking and biostatistics
3) to allow for group mentoring and careful monitoring of the trainees’ progress and the overall success
of the training program
4) to address the critical shortage of adult hematologists pursuing careers in academic hematology

Public health relevance
The goal of this Program is to attract and to train exceptional postdoctoral fellows for careers in academic adult hematology. Improved understanding of stem cell biology, hemoglobinopathies, thrombotic microangiopathies, bone marrow failure states, and myeloproliferative diseases will aid in translating laboratory findings into novel clinical therapies.